Distinguishing features of C. albicans pseudouridylation and their roles in pathogenesis

Project Summary
The human fungal pathogens C. albicans and C. auris are members of the CTG fungal clade which diverged
roughly 200 million years ago from the Saccharomyces lineage. Work from previous funding periods suggests
pseudouridylation and pseudouridine degradation are not conserved between CTG and Saccharomyces
lineages. The Bernstein Lab will continue to characterize these processes in C. albicans and expand
investigations to C. auris, an important emerging fungal pathogen with isolates that are resistant to all known
antifungal therapeutics. This work will reveal fundamental differences in RNA modification processes between
fungal lineages. Furthermore, the processes of pseudouridylation and pseudouridine degradation are not
conserved in mammals, but some appear to be conserved in additional fungal pathogens.
Pus1 is a pseudouridine synthase predicted to modify a variety of RNA substrates. In Aim 1, experiments will
explore how heavy metals affect C. albicans Pus1 localization, determine if Pus1 A and B alleles interact with
distinct cohorts of proteins, identify Candida nuclear targeting sequences, and identify Pus1 substrates. This
work will be carried out by undergraduate and master’s students and will answer long standing questions
regarding allele heterogeneity and stress response in C. albicans.
Pug1 degrades pseudouridine. Aim 2 experiments will determine if abrogation of pseudouridine degradation
affects C. auris growth, biofilm formation, or antifungal tolerance; identify Pug1 interactors; and determine if
PUG1 deletion leads to a defect in virulence using a wax moth and planaria model system. This will be the first
characterization of pseudouridine degradation in C. auris and one of the first characterizations of RNA
metabolism in C. auris. Undergraduate and master’s students will be involved in all aspects of the proposed
experiments providing excellent training opportunities for a diverse team of students.
In addition to these two Aims, two of the classes designed and taught by the PI each year will be leveraged
to provide the undergraduate and master’s students taking those classes an opportunity to examine important
appropriate aspects of molecular and fungal biology. As part of their in-class laboratory activities, between 25
and 50 undergraduates a year will participate in focused research projects, working on important research
questions using innovative approaches under direct supervision of the PI.
The 2022 NIAID strategic plan states one of the Institute’s priorities is to “support basic and clinical research
to better understand, diagnose, treat, and prevent infectious diseases and immune-mediated disorders—many
of which have far-reaching global consequences—including fungal diseases.” Consistent with this vision, our
research investigates RNA modifications in two important human fungal pathogens, C. albicans and C. auris.
Our work seeks to better understand how these pathogens differ from humans at the molecular level. As such,
this research has the potential to identify novel antifungal targets.

Public health relevance
Project Narrative To develop more effective antifungal treatment options, what distinguishes fungal pathogens from humans at the molecular level must be understood. Undergraduate and master’s students in the Bernstein Lab will leverage innovative technologies to investigate differences in pseudouridine synthesis and degradation between fungal pathogens and humans. The proposed research will use cutting-edge techniques to train biomedical investigators, has the potential to discover novel antifungal targets, and will lead to a better understanding of pseudouridine metabolism.